Targeted Transcutaneous Stimulation to Restore Autonomic Cardiovascular Health in Veterans with Spinal Cord Injury

PROJECT SUMMARY/ABSTRACT
Dr. Caitlyn Katzelnick has been working with investigators in the National Center for Spinal
Cord Injury (SCI) and Immobilizing Conditions at the VA Medical Center, Bronx, NY for eight
years as a senior research coordinator. Along with her Primary Mentor, Dr. Wecht, Caitlyn has
been studying the effects of cardiovascular, cerebrovascular and cognitive dysfunction post SCI,
and the results of her Doctoral dissertation suggest that increased arterial stiffness in
individuals with SCI may relate to the degree of decentralized sympathetic cardiovascular
control and increased reliance on the renin-angiotensin-aldosterone system (RAAS) for
maintenance of orthostatic blood pressure (BP). Recent evidence indicates that increased
arterial stiffness is an independent predictor of cardiovascular disease risk, which may
contribute to the heightened cardiovascular morbidity and mortality in the SCI, compared to the
general population. Increased reliance on the RAAS is believed to mitigate orthostatic falls in
BP and reduce the severity of symptoms reporting; however, findings in the general population
link the RAAS with vascular restructuring and remodeling. Therefore, clinical intervention to
stabilize and normalize BP should be a priority in hypotensive individuals with SCI. Advances in
methods of neuromodulation of the spinal processes offer a non-pharmacologic approach to
restore endogenous autonomic cardiovascular control and improve orthostatic BP control.
Based on our present understanding of the somatovisceral integration within the spinal cord, it
is plausible that transcutaneous spinal cord stimulation (TSCS) can be targeted to excite and
modulate appropriate spinal autonomic circuitry to rapidly normalize orthostatic BP; however,
electrode placement and stimulation parameter mapping is needed to optimize orthostatic BP
control. Therefore, our primary aim is to identify an individualized map using noninvasive
TSCS of the spinal autonomic circuitry that results in an increase of seated BP. Our secondary
aim is to compare BP, plasma concentrations of norepinephrine, renin and aldosterone during a
head-up tilt with and without optimal TSCS. This investigation will be completed at the brand-
new Center of Spinal Stimulation, located at the Kessler Foundation, which is home to our VA
satellite center. Dr. Katzelnick will have access to all the necessary facilities and equipment
including: TSCS, electromyography (EMG) and cardiovascular. The CDA-1 will provide Dr.
Katzelnick with the advanced skill training, clinical research experience, and mentorship to
facilitate her growth into an independent VA investigator. Training objectives include: 1)
administering and mapping TSCS; 2) gaining an understanding of EMG recordings and
analysis; and 3) assaying the RAAS hormones. Dr. Katzelnick will take academic courses to
advance her knowledge base in grant writing, cardiovascular physiology, statistics, biophysics
and EMG. Her mentors encompass various relevant scientific backgrounds, which converge with
a similar understanding of secondary consequences after a SCI. It is anticipated that these data
will begin to establish a standard methodology for TSCS mapping of spinal autonomic circuits to
promote restoration of cardiovascular health, and overall well-being in Veterans with
immobilizing conditions. Standardized TSCS methodology will be used in future grant
applications, including a CDA-2 application, to promote improved vitality and quality of life in
Veterans with SCI.

Public health relevance
PROJECT NARRATIVE Autonomic nervous system dysfunction and blood pressure (BP) fluctuations contribute to the increased cardiovascular disease risk in the spinal cord injury (SCI) population; however, treatment of BP fluctuations is not a clinical priority. This is due, in part, to the lack of safe and effective interventions, even though mounting evidence strongly supports adverse effects of BP instability on cognitive function and quality of life. Identifying individualized transcutaneous spinal cord stimulation (TSCS) parameters that safely and effectively increase and stabilize BP in Veterans with SCI will provide the foundational evidence to support eventual wide-spread clinical utility throughout the VA healthcare system. It is anticipated that these data will begin to establish a standard methodology for TSCS mapping of spinal autonomic circuits to promote restoration of orthostatic BP, improve independence and quality of life for Veterans with SCI.